De novo design of artificial haloperoxidase enzymes

Project Summary/Abstract
Understanding the relationships between three-dimensional protein structure, metal reactivity, and catalytic
function promises routes to new drugs and treatments, green chemical processes, and bespoke catalysts.
However, the complexity of natural metalloenzymes makes the design of wholly new enzymes one of the
greatest challenges in chemical biology. Thus, the de novo design of functional metalloproteins, in which both
the protein scaffold and metal-containing active site are designed “from scratch”, presents the most stringent
test of our understanding of protein folding and protein-metal structure-function relationships. Using new
machine-learning tools for protein design and structure prediction, this work will investigate metalloenzyme
structure-function relationships though the de novo design of vanadium- and heme-dependent
haloperoxidase enzymes. These enzymes oxidize halides (X–) to X+ using H2O2 to promote halogen
incorporation into diverse organic substrates. Halogen atoms often greatly increase the bioactivity of organic
compounds, making these reactions important both for human health (e.g., pharmaceuticals, hormones,
antibiotics) and the environment (e.g., toxic and ozone-depleting aerosols such as bromoform). The designed
proteins will be expressed and characterized using a diverse array of structural, biophysical, and
spectroscopic methods. Haloperoxidase activity will be measured, and the effects of primary and secondary
sphere mutations will be studied. Potential alternative reactions catalyzed by the enzymes will be assayed,
and the binding and activities of similar metal-oxo species (e.g., MoO42–, WO42–) will be investigated. By
designing haloperoxidases using only minimal starting motifs, this work will provide valuable insights into the
requisite structural and chemical features enabling efficient haloperoxidation catalysis.

Public health relevance
Project Narrative Proteins use metal ions to catalyze myriad important reactions with relevance to human health and the environment. Understanding the detailed interactions between three-dimensional protein structure, metal ions, and catalytic function, promises improved understanding of diseases and routes to new drugs and treatments. This work will investigate metal-protein structure-function relationships by designing artificial metalloenzymes that catalyze haloperoxidation reactions.